Dichotomous roles of Shroom3 in Tubular cells and Podocytes in native and allograft kidneys

Project Summary: Chronic kidney disease (CKD) is identified as decline in renal function estimated by
glomerular filtration rate (eGFR) and/or signified by the presence of proteinuria. By histology in native and
allograft kidneys, CKD is characterized by renal interstitial fibrosis, vascular intimal fibrosis and glomerulo-
sclerosis, reflecting damage to different renal compartments. Genome-wide association studies (GWAS) have
identified candidate susceptibility loci for CKD. The mechanistic basis of GWAS-variant associations with CKD
are largely undescribed, hindering translation of GWAS information for the development of novel therapies for
CKD. We previously showed that a CKD-associated SHROOM3 locus - Rs17319721, in the donor kidney
increased SHROOM3 expression (by TCF7L2-dependent transcription) and promoted renal allograft fibrosis
(IF/TA), through TGF-β1 signaling. These data contrast with evidence of a protective role for Shroom3 in
glomerular development. Consistently, opposing associations were seen between glomerular- and non-
glomerular SHROOM3, and renal function in CKD biopsies. In allografts, homozygosity at Rs173198721 ie
A/A, which associated with lower GFR, was associated with reduced albuminuria by 2-years post-transplant.
GWAS data also showed that Rs17319721 was associated with reduced albuminuria but reduced eGFR. To
study mechanism of these dichotomous effects, we used inducible Shroom3 knockdown mice and observed
reduced renal fibrosis with tubular Shroom3 knockdown. In tubular cells, Rho kinase (ROCK) inhibitors or
ROCK-binding (ASD2-) domain deletion in Shroom3 reduced profibrotic signaling. Conversely, glomerular-, but
not tubular-Shroom3 knockdown, induced albuminuria with diffuse podocyte foot process effacement without
podocyte loss. This phenotype is similar to human minimal change disease (MCD). In podocytes, we identified
& confirmed the novel interaction of SHROOM3 with FYN (a Src kinase) via a critical Src homology-3 binding
domain, distinct from its ASD2-domain. In vitro and in vivo, Shroom3-Fyn interaction was required for activation
of Fyn kinase and downstream Nephrin phosphorylation and actin cytoskeleton in podocytes. This novel
mechanism explains the protective effect of Shroom3 (& Rs17319721) on proteinuria in adults. We
hypothesize that SHROOM3 has dichotomous roles in renal tubular cells and podocytes, that are mediated by
distinct protein motifs. We will test our hypothesis by three aims. In aim-1, we will overeprexpress ASD2-
domain deficient Shroom3 in vitro/in vivo to confirm ASD2-domain dependent profibrotic signaling by Shroom3.
In aim-2, Fyn-binding mutant Shroom3 will be overexpressed to confirm podocyte injury and phenotype in vivo.
Since impaired Fyn activation is associated with MCD, and Shroom3 knockdown inhibited Fyn, in aim-3, we
will investigate the relevance of Shroom3-Fyn interaction to human MCD by comparative glomerular
morphometry and genomics utilizing human data from the Nephrotic syndrome NEPTUNE consortium. This
work is essential to developing domain-specific Shroom3 inhibitors for fibrosis in CKD and IF/TA.

Public health relevance
Project Narrative: Many patients with CKD will progress and there is an urgent need for therapies, & we showed SHROOM3 was a promising candidate where antagonizing it reduced fibrosis in kidneys carrying a common mutation (ie A- allele). However this contrasted a protective role for SHROOM3 in glomeruli, implying Shroom3-antagonism may create glomerular injury, an effect needing to be circumvented. Our work showing that different functional parts of the protein are responsible for opposing effects protective (in glomeruli) and adverse (in tubular cells), will allow specific targeting of Shroom3 as therapy for CKD.